Chemical Approaches to Study Protein Post-translational Modifications

Summary
Most biological events in the cell are mediated at some level by protein post-translational modifications. For
example, aberrant protein phosphorylation catalyzed by kinase and phosphatase enzymes is linked to a
wide variety of cancers. Similarly, the unregulated acetylation state of histone proteins, controlled by histone
deacetylase (HDAC) proteins, can lead to epigenetic changes in transcription and ultimately disease. Key
to characterizing both healthy and disease states is a detailed molecular understanding of the role played
by protein post-translational modifications, such as phosphorylation and acetylation, on protein function and
interactions. Importantly, enzymes regulating protein post-translational modifications, including kinase,
phosphatase, and HDAC proteins, are targets of therapeutics. Yet, tools linking specific protein
modifications to downstream biological activities are often limited or unavailable, which has stalled progress
in disease characterization and drug development.
The NIGMS-funded projects in the Pflum lab address the critical need to develop innovative chemical
approaches to discover unanticipated roles of protein post-translational modifications and their modifying
enzymes in cell biology. In our work with protein phosphorylation, we pioneered use of g-phosphoryl
modified ATP analogs in kinase-catalyzed labeling reactions. Building on this prior work, we propose in the
next 5 years to 1) develop a new suite of methods with unique abilities to probe kinase- and phosphatase-
substrate pairs and multi-protein complexes in cells, and 2) apply our innovative tools to a variety of
biological problems in collaboration with biologists. In our work with protein acetylation, we have
demonstrated the power of using inactive mutants as traps to discover non-histone substrates of HDAC1
and HDAC6, which has revealed unexpected roles in cell biology. In the next 5 years, we will apply this
powerful trapping strategy to additional HDAC protein isoforms, which will establish the role of HDAC
proteins in activities beyond epigenetics and transcriptional regulation. In a new direction for the program,
trapping will be expanded to demethylase enzymes, which regulate protein methylation. Given the critical
role of kinase, phosphatase, demethylases, HDAC enzymes in disease and drug treatment, yet the
inadequate tools available to study these enzymes in complex cellular systems, the enabling chemical
strategies proposed in this application will strengthen biomedical research in cell biology and drug design.

Public health relevance
Narrative Protein post-translational modifications mediate myriad of cellular events, and unregulated protein modifications are widely associated with disease states. The program aims to develop chemical approaches to characterizing the enzymes governing three protein modifications, acetylation, methylation, and phosphorylation, which will lead to a greater understanding of disease formation and development of new treatments.